Investigation of a mitochondria-associated metastasis regulatory mechanism

Lung cancer is the leading cause of cancer-related death in the United States, and more than 150,000
Americans die of lung cancer each year. Despite our best treatment, efforts to cure lung cancer have failed in
most cases, partly due to an insufficient understanding of the biology of metastasis, which almost inevitably leads
to lung cancer death. Therefore, understanding better the mechanism regulating metastasis will allow us to gain
deeper insights into the disease basis, on which novel therapeutic strategies for treating metastatic lung cancer
can be developed and tested. On the basis of our preliminary studies, we posit that an autophagy related gene
plays a critical role in the regulation of lung cancer metastasis through a novel mitochondria associated
mechanism. The primary objectives of this proposal are to determine whether manipulating the expression of this
gene or its mitochondria associated function can inhibit the dissemination of lung cancer. As such, our studies
not only reveal a new basic mechanism for lung cancer, but have translational potentials. Because there are
about 2 million new lung cancer cases each year globally (World Health Organization statistics), our studies may
have a major impact on public health.

Public health relevance
Lung cancer remains one of the deadliest malignancies in the United States. Metastasis is the main cause of lung cancer patient death. Our application focuses on a novel mechanism regulating lung cancer metastasis and the role for autophagy related gene in this process. Our studies are expected to not only improve our understanding of the ways in which lung cancer metastasizes, but also form the basis for future developing novel therapeutic strategies for this deadly disease.